Leveraging whole-exome sequence data from diverse biobanks and cohorts to study rare coding variation in prostate cancer

Abstract
There is strong evidence that prostate cancer (PCa) is a heritable phenotype. In addition to greater risk observed
in men with a family history of PCa, genome-wide association studies (GWAS) have identified over 400 common
independent risk variants, which explain ~40% of the familial risk. It is increasingly recognized that much of the
unknown heritability for PCa may also be due to variants of low minor allele frequency (<1%). While large, multi-
ancestry genome-wide reference panels (e.g., TOPMed) have been developed to facilitate studies of less
common alleles (down to 0.1%), they cannot be used to enumerate and accurately study very rare alleles that
can only be characterized via sequencing. Pathogenic variants in DNA repair pathway genes (e.g., BRCA2,
ATM, NBN, CHEK2, PALB2), identified through candidate gene studies, provide strong support for exceedingly
rare (<0.1%) protein coding variation contributing to overall PCa and aggressive disease susceptibility.
Unfortunately, we remain limited in our ability to comprehensively survey and study very rare variation genome-
or exome-wide due to high sequencing costs, limiting current sample sizes. Here, we propose to combine existing
whole-exome (WES) and whole-genome (WGS) sequence data from multi-ancestry biobanks and cohorts to
conduct the first, large-scale study of rare coding variation in PCa and to integrate tumor somatic and germline
mutation data to elucidate the biology of gene-risk associations. In Aim 1, we will leverage existing WES data for
>90,000 PCa cases (58,000 European ancestry, 20,000 African ancestry, 4,000 Asian ancestry and 6,700
Latino/Hispanic) and >500,000 controls within biobanks and cohorts in the US and UK and conduct exome-wide
analyses of overall PCa and aggressive disease phenotypes. In Aim 2, we will examine the combined effect of
rare coding variants and a polygenic risk score (PRS) on risk of overall PCa and aggressive disease and estimate
absolute risks for the combined effects of rare coding variants and PRS in prospective biobanks and cohorts
across populations. In Aim 3, we will integrate somatic tumor and germline variation data to inform genes and
biological pathways involved in PCa and aggressive disease. For this Aim, we have assembled a somatic
resource of >7,000 PCa patients with germline exome/PRS data and somatic mutation profiling from WES and
WGS studies, including >2,000 with transcriptomic data. We expect this study to provide the most comprehensive
and well-powered examination of rare coding variation in PCa across populations to date. Findings from this
study will have immediate clinical translation by informing personalized risk prediction and the development of
novel risk-based screening strategies for overall and aggressive PCa. Integrating germline and somatic data will
also define biological mechanisms that may be clinically important for understanding how to treat and prevent
PCa and lethal disease across populations.

Public health relevance
Project Narrative In this project, we will conduct exome-wide discovery efforts to identify rare variants and genes that contribute to risk of prostate cancer and aggressive disease in men of European, African, Asian and Latino ancestry. We expect findings from this study will make a major contribution to our understanding of genetic susceptibility to prostate cancer and will have widespread applicability and significance, leading to better risk models to more accurately predict a man's risk of developing prostate cancer and aggressive disease.